Development of novel approaches for gene editing therapies of cystic fibrosis

SUMMARY
Chronic lung infection is the primary cause of death in patients with cystic fibrosis (CF). CF is caused by
mutations in the cystic fibrosis transmembrane conductance regulator (CFTR) gene. Currently, CFTR modulators
are effective in treating most CF patients, but this pharmaceutical rescue is costly, necessitates a lifelong
commitment and provides no benefit to those who produce insufficient or no CFTR. Gene therapy remains the
best hope for a cure applicable to all CFTR genotypes, and it would be less expensive than current modulator
therapy. For gene therapy to become feasible, current strategies for CFTR addition, which lead to unregulated
CFTR expression, must be adapted to reproduce the cellular heterogeneity of CFTR expression in the lung. This
is essential for bacterial clearance and innate immunity. CRISPR-based gene editing holds promise for correcting
the defect in CFTR without altering its endogenous regulation, and permanent correction is achievable by
targeting the airway progenitor stem cells. However, the cell-cycle dependent homology-directed repair (HDR)
is inefficient for application to the terminally differentiated airway epithelial cells and quiescent basal stem cells
of the lung airways. Here we propose to overcome the inefficiency of the current HDR approach with homology-
independent targeted integration (HITI), which has shown promise for correcting genetic defects in post-mitotic
cells in vivo. We hypothesize that a mutation-free CFTR gene can be rebuilt by using HITI to trap a pre-spliced
CFTR mega exon (associated with splicing acceptor) in a desired intron. rAAV2.5T efficiently transduces multiple
epithelial cell types (including basal stem cells) in polarized human airway epithelium (HAE) cultures, as well as
in ferret lung airways. We will use rAAV2.5T to deliver the components necessary for editing by HITI and evaluate
the effectiveness of the HITI approach in correcting the CF phenotype both in vitro, using polarized HAE cultures
derived from CF patients, and in vivo, using a G551D CF ferret model. However, the clinical utility of rAAV2.5T
is currently limited by the need of pharmaceutical augmentation, because its transduction in polarized airway
epithelium requires the co-administration of doxorubicin (Dox) to overcome a significant post-entry block to
nuclear entry. To address this limitation, we will apply the insights gained from our preliminary studies on
rAAV2.5T transduction biology to develop a next-generation rAAV2.5T vector. Specifically, we will create random
mutants of the N terminus of the large capsid protein VP1 (VP1N), which plays a crucial role in vector
translocation from the trans-Golgi network (TGN) to the nucleus in productive transduction. By directed evolution
of the libraries in polarized HAE cultures, we will screen for AAV2.5T variants that efficiently transduce airway
basal cells in the absence of Dox. The lead mutants from the screening will be evaluated for efficiency of
transduction in HAE cultures and ferret airways in the absence of Dox, the best-performing variant will be used
in the HITI gene editing approach. We expect that a therapeutic genome editing approach is feasible for
permanent correction of mutations in CFTR for CF gene therapy, using a Dox-independent rAAV2.5T vector.

Public health relevance
PROJECT NARRATIVE This proposal will use rAAV-delivered and CRISPR-mediated gene editing in airway progenitor cells to permanently correct the defects in CFTR gene in cystic fibrosis patients. In addition, it will develop the next generation rAAV vector aligned with the gene editing approach in airway progenitor cells.